Barriers and predictors of physical fitness among volunteer firefighters

PROJECT SUMMARY
Cardiovascular disease is the leading cause of on-duty deaths among firefighters. Firefighters incur acute health
risks including injury, fatigue, heat stress, and cardiovascular strain while protecting our communities.
Appropriate physical fitness is an essential part of reducing these risks. Poor physical fitness, including low
cardiorespiratory fitness and high body mass index, can contribute to increased risks of adverse cardiovascular,
respiratory, and cancer (colorectal, prostate) outcomes, all major concerns among firefighters. The United States
has 1.1 million firefighters, 67% of whom are volunteer firefighters. However, most firefighter heath research is
conducted among career (paid) firefighters. While volunteer firefighters train for, and perform the same tasks as
career firefighters, they differ in key ways that may lead to lower physical fitness maintenance. Volunteer
firefighters are always on call for emergency responses, do not spend extended time in the fire station, and are
expected to maintain training while balancing their primary employment and family life, reducing opportunity for
fire-department promoted health programs. In this proposal, we investigate the predictors and barriers of physical
fitness among volunteer firefighters, which are critical for developing health promotion programs targeted at this
understudied majority.
The proposed mixed-methods project will be conducted within the research infrastructure of the New Jersey
Firefighter Cancer Assessment and Prevention Study, and will use previously collected survey data on
firefighting and behavioral factors, and focus group data on individual- and fire-department level factors affecting
physical fitness among volunteer firefighters. Volunteer firefighters will be compared to career firefighters from
the national Fire Fighter Cancer Cohort Study. The proposed project has three specific aims: (1) To identify
factors associated with physical fitness among firefighters and assess differences among volunteer and career
firefighters; (2) To qualitatively explore potential individual- and fire-department level influences on physical
fitness among volunteer firefighters; and, (3) To employ a mixed-methods analysis by triangulating quantitative
and qualitative data regarding factors associated with physical fitness among volunteer firefighters. Multivariable
regression analysis will be used to assess effects of behavioral factors and firefighter service exposures on
physical fitness among volunteer firefighters compared with those for career firefighters. Thematic analysis will
be used to generate an in-depth understanding of the barriers and promoters of physical fitness among volunteer
firefighters. A convergent mixed-methods analysis will integrate quantitative and qualitative findings to explore
how and why health behaviors and volunteer firefighting characteristics influence physical fitness. By
investigating the predictors and barriers of physical fitness among volunteer firefighters, specific physical fitness
and health promotion strategies can be informed.

Public health relevance
PROJECT NARRATIVE There is evidence of sub-optimal physical fitness among United States firefighters, which can adversely impact their health, and endanger the communities they serve. The United States has 1.1 million firefighters, 67% of whom are volunteer firefighters. By investigating the predictors and barriers of physical fitness among volunteer firefighters, health promotion strategies can be developed to improve the health of this understudied majority who protect our communities.